Clinical Neuroscience Research Training in Psychiatry

DESCRIPTION (provided by applicant): Clinical Neuroscience Research Training in Psychiatry This training program, now in its 15th year, is designed to meet the national goal of increasing the number of fully training psychiatric physician-scientists conducting clinical and translational patient-oriented research in mental health. In order to be effective independent investigators, psychiatric physician-scientists must be fully trained in both clinical neuroscience and modern clinical-translational research methodologies. The ever- increasing complexity of the science and methods require that individuals receive specialized training in order to take full advantage of the rapid advances occurring in the field. This program will utilize a curriculum designed to give the trainee mastery of the fundamentals of basic molecular and cellular neurobiology, neuropharmacology, neuroimaging, psychiatric genetics and the responsible conduct of psychiatric research in human subjects. Trainees will benefit from individualized mentorship by members of a large and multidisciplinary group of research faculty within the Department of Psychiatry. The rich training environment is supported by a number nationally funded research programs / infrastructures within the Department of Psychiatry, including the: 1) Clinical Neuroscience Research Unit, 2) Interdisciplinary Research Consortium on Stress, Self-Control, and Addiction, 3) National Center for Neurobiological Study of Post-Traumatic Stress Disorder, 4) Center for the Translational Neuroscience of Alcoholism, 5) Neurobiological Studies Unit, 6) Neuroimaging Program (that includes PET, SPECT, fMRI, MRS, and DTI), 7) Psychotherapy Development Research Center, and 8) Program in Human Psychiatric Genetics. Trainees will conduct their research studies in specialized inpatient and outpatient research facilities and specialty clinics, and the resources from other basic science programs within the Department and Medical School will also be utilized. For the past 50 years, the Research Faculty in the Department, and its alumni, have had an outstanding track record of training nationally and internationally prominent researchers in psychiatry. The renewal of this application seeks stipends for 5 postdoctoral fellows per year and will allow this program to continue to succeed in increasing the number of fully trained, clinical-translational patient-oriented research psychiatrists nationally. PUBLIC HEALTH RELEVANCE: In its most severe and incapacitating forms, mental illness affects up to 2-3% of the population, and in milder forms, as high as 10-15% of the population. Given the complexity of the problem, a new generation of psychiatrists will need training in the most advanced clinical-translational research methods if breakthroughs are to emerge. Thus, the current training program will recruit and train psychiatrists as physician-scientists in the clinical-translational neuroscience of mental illness.

Public health relevance
In its most severe and incapacitating forms, "mental illness" affects up to 2-3% of the population, and in milder forms, as high as 10-15% of the population. Given the complexity of the problem, a new generation of psychiatrists will need training in the most advanced clinical-translational research methods if breakthroughs are to emerge. Thus, the current training program will recruit and train psychiatrists as physician-scientists in the clinical-translational neuroscience of mental illness.